Vascular Remodeling is a Crucial Factor in the Progression of Hypertrophic Cardiomyopathy

Abstract:
Our investigations into the early irreversible progression in hypertrophic cardiomyopathy and the lack of effective
treatments has led us to concentrate on the coronary microvasculature. Clinical studies have been characterizing
the deleterious vascular alterations occurring in the disorder, but further investigations into the underlying
mechanisms behind this relationship have been minimal. The experiments proposed within the proposal will
begin to answer the role perfusion and vascular dysfunction play in the progression of hypertrophic
cardiomyopathy. Given the mechanical and energetic deficiencies in the disorder, it is likely that they impede
physiological coronary flow that drives remodeling of vessels. These relationships and influencing factors will be
looked more closely into. The endothelial dysfunction within the myocardium is expected to have a substitution
of the primary vasodilator nitric oxide to ROS signaling as is stereotypical of vascular dysfunction. We will
therefore make efforts to understand this switch between vasoactive molecules and its impact on coronary
alterations. We will lastly attempt to modify the endothelial function in hypertrophic cardiomyopathy with an
sphingosine-1-phosphate analog, FTY720, to prevent the irreversible progression established early on.

Public health relevance
Project Narrative: Hypertrophic cardiomyopathy is a progressive genetic disorder that establishes an irreversible remodeling program that starts early in postnatal development. With the lack of effective treatments, it has become necessary to drive investigations in a new direction by focusing on the mechanisms and functional consequences of microvascular alterations in respect to disease pathophysiology. In this proposal we describe approaches that will elucidate the instigators and mechanistic pathways underlying coronary microvascular dysfunction as well as targeting the vessels with FTY720 (known as fingolimod and used for treatment of multiple sclerosis) in an attempt to prevent irreversible cardiac remodeling.